Genetic control of developmental timing

1
Project Summary/Abstract
Development of even the simplest of multicellular animals is astonishingly complex, involving the spatial
and temporal orchestration of cellular proliferation, differentiation, and morphogenesis throughout the
developing organism. The success of the species demands that its developmental programs are robust and
resilient in the face of environmental and physiological perturbations – ‘everyday stresses’ that the developing
animal’s circumstances routinely present. We study how genetic regulatory networks (GRNs) control temporal
patterns of developmental events in animals, with an emphasis on understanding how microRNAs and other
post-transcriptional regulators contribute to the robustness and stress resilience of animal development. We
have worked primarily with the nematode Caenorhabditis elegans (C. elegans), studying a set of genes (the
‘heterochronic genes’) whose products function in a GRN that controls the timing of developmental cell fate
transitions during larval development. At the core of the heterochronic GRN is the developmentally dynamic
deployment of transcription factors that specify stage-specific cell fates for diverse cell types, under the control
of microRNAs and RBPs that regulate the precisely timed changes in the levels of those transcription factors.
C. elegans developmental timing offers an advantageous system to study developmental robustness, owing to
the remarkably invariant cell lineage development of the wild type despite the free-living lifestyle of larvae, who
grow up ‘in the wild’ foraging in the soil for microbial food. Consistent with roles for microRNAs in developmental
robustness, the phenotypes of microRNA gene mutants are often conditional -- modifiable by environmental or
physiological stresses that have no impact on wild type developmental fidelity. Our aim for the next 5 years is
to advance mechanistic understanding of how microRNAs collaborate with other noncoding RNAs and RNA
binding proteins (RBPs) to enable stress-robust specification of developmental cell fates. Our research plan will
continue to leverage C. elegans developmental timing for discovery and characterization of how microRNAs
collaborate with other regulators to enable stress-robust heterochronic GRN functionality. We also have added
new elements to our research, involving the study of microRNAs in whole-body regeneration of the Acoel worm,
Hofstenia miamia (H. miamia). The capacity for tissue replacement and regeneration is essentially universal
across multicellular animals, presumably reflecting evolutionary roots in mechanisms of whole-body
regeneration possessed by our ancient bilaterian ancestor. We view whole body regeneration as a particularly
stressful context for an animal, involving as it does abrupt changes in gene expression, proliferation, and cell
fate specification. We anticipate that new understanding of evolutionarily ancient functions of microRNAs in
stress robustness can emerge from these H. miamia studies of whole-body regeneration.

Public health relevance
Genetic and genomic analyses of the nematode roundworm C elegans and the Acoel worm H miamia will be directed towards understanding the roles of microRNAs and other post-transcriptional regulators of gene expression in enabling stress-resilient developmental progression and tissue regeneration in animals.